Using Digital Solutions to Improve Transition of Care for Patients with Acute Kidney Injury

Title: Using Digital Solutions to Improve Transition of Care for Patients with Acute Kidney Injury
The overarching objective of the proposed mentored patient-oriented career development award (K23) is to
develop an acute kidney injury (AKI) research program that utilizes behavioral science principles and digital
health solutions, fostering Dr. Ng’s development to an independent researcher.
AKI, a sudden decline in kidney function, occurs in 16-25% of hospitalized patients. If AKI is not addressed
during the transition of care from the hospital to outpatient setting, patients are at risk for recurrent AKI and
rehospitalization. Achieving optimal transition of care for AKI is challenging, because AKI information is poorly
communicated both to outpatient providers and patients. Outpatient providers cannot address AKI
complications nor monitor kidney function, when they are unaware of patient’s AKI status. Additionally, patients
lack the knowledge and self-management skills for AKI (e.g., follow kidney-specific dietary restrictions or avoid
medications harmful to the kidneys). To improve AKI information flow to providers and patients, the candidate
proposes to adapt and evaluate: 1) an AKI section for discharge summary; and 2) the feasibility of a text
messages to support patient education and self-management. The Specific Aims are: 1a) adapt existing
discharge summary to include AKI information, and test usability; 1b) design and adapt text messages for an
AKI management and education tool (AKI-MET); and 2) evaluate the feasibility, acceptability, and preliminary
efficacy of intervention components in a 2 sequential pilot RCTs.
Dr Ng has completed a master’s degree in clinical epidemiology at the University of Pennsylvania, through
which she gained experience in epidemiology, biostatistics, and study design. Her previous training and
experience in AKI epidemiology research and qualitative research have prepared her to engage in the work
proposed in the studies. Dr Ng is positioned to use this award to launch an independent research career in the
rich research and training environment at the Zucker School of Medicine at Hofstra/Northwell. Through her
proposed career development, she seeks to gain skills in: 1) application of health information technology and
digital health intervention; 2) behavioral science and behavioral intervention design; 3) RCT design, conduct,
and analysis, including longitudinal data analysis from the pilot trial; and 4) professional development. Dr. Ng
has assembled a multi-disciplinary mentorship team led by experts in the field. Upon completion of these K23
activities, she will be well-positioned to submit an R01 for a larger RCT to assess the effectiveness of AKI
transition-of-care tool in improving health outcomes.

Public health relevance
PROJECT NARRATIVE The care for patients with acute kidney injury (AKI) is suboptimal when they transition from hospital to outpatient care, yet challenging to overcome because of poor AKI communication both to outpatient providers and patients. To improve AKI information flow to providers and patients, the proposed study aims to develop and evaluate AKI discharge summary tool in the electronic health records, and text messaging tool that supports patient education and self-management behavior. Improving AKI communication through these tools will improve the clinical care of patients with AKI and reduce morbidity.